Institutional Career Development

Health research is undergoing dramatic change fueled by groundbreaking technological innovations, the
increasing availability of big data, growing prominence of cross-disciplinary team science and constraints on
health research funding. This new world demands that successful researchers have a dynamic and evolving
mastery of a broad set of disciplines and must be avid collaborators and lifelong learners. At the Boston
University CTSI we have crafted an innovative career development program that addresses these needs and
we request funding to support this innovative and integrated program. Our vision encompasses two specific
aims as follows: 1. Build a system that provides continuous comprehensive mentoring and career
development support for scholars from postdoctoral training through early faculty years 2. Anticipate
the skills that scholars will need for future success in research and provide these in an ongoing fashion
in the curriculum.
At BU and its affiliates there is an extensive breadth of research, a wealth and diversity of existing training
programs, a comprehensive curriculum, an abundance of accomplished and invested mentors, and close
collaborations between basic scientists and clinicians and clinical scientists. Among special institutional strengths
that foster the development of junior faculty are a vibrant faculty development program, pilot award program, and
commitment to core resources and cutting-edge technologies.
The program is targeted to our K community of investigators. It includes all junior faculty who are in K programs:
KL2 scholars, NIH K grant recipients and junior faculty with other career development awards (including awards
provided by institutional funds). It also includes postdoctoral fellows. A major goal of our career development
program is to provide support to scholars across the continuum of their careers. For junior faculty with
career development support including those beginning KL2 support, we have developed the PRIME Program
(Pathway to Research Independence and Mentoring Excellence) program. This program provides mentoring,
interactive instruction, reviews of works in progress and mock grant reviews to support these scholars during
their early career development through submission of their first scientific grants. Our ultimate goal is to create
a cadre of well-educated translational researchers who have the skills and passion to contribute to improving the
health of the communities we serve.